PI3K Signaling in Juvenile Myelomonocytic Leukemia

DESCRIPTION (provided by applicant): Juvenile Myelomonocytic Leukemia (JMML) is a lethal myeloproliferative disorder (MPD) of children, characterized by unregulated proliferation of myelomonocytic cells and hypersensitivity to granulocyte-macrophage colony-stimulating factor (GM-CSF). Most patients show hyperactivation of the Ras signaling pathway, including activating mutations in PTPN11, which encodes the protein tyrosine phosphatase, Shp2. It has been shown that, in response to GM-CSF stimulation, gain-of-function mutations in Shp2 result in elevated levels of phospho-Akt, a downstream effector of the phosphoinositol-3-kinase (PI3K) pathway. The lipid kinase PI3K is a heterodimer consisting of one of two regulatory subunits, p851 or p852, and one of three catalytic subunits, p1101, p1102, or p1104, whose action is antagonized by the lipid phosphatase PTEN. Previously, we demonstrated that genetic interruption of p851 results in partial correction of mutant Shp2-induced hyperproliferation in vitro. Accordingly, we hypothesize that gain-of-function mutant Shp2-mediated hyperactivation of the PI3K pathway contributes to the etiology of JMML. To explore this hypothesis, we propose the following three aims: (1) We will use murine hematopoietic cells lacking expression of both PI3K regulatory subunits p851 and p852, with activating PTPN11 mutants to explore the hypothesis that both p85 subunits contribute to gain-of-function mutant Shp2-mediated GM-CSF hypersensitivity. These studies will include (A) in vitro biochemical and functional analysis, and (B) in vivo transplant studies to examine the development of MPD. (2) We will cross conditional Shp2 D61Y gain-of-function knockin mice with conditional PTEN knockout mice to assess if PTEN deficiency will (A) accelerate and exacerbate development of activating PTPN11-induced MPD in vivo, and (B) result in increased Shp2 D61Y-induced hyperproliferation and Akt phosphorylation in vitro. (3) Finally, to explore the hypothesis that reduced nuclear PTEN contributes to gain-of-function mutant Shp2-induced PI3K hyperactivation, we will (A) co-transduce conditional PTEN knockout bone marrow cells with gain-of-function mutant Shp2 E76K and WT PTEN or mutant PTEN K289E, which abrogates monoubiquitination-mediated nuclear translocation, in order to investigate if inhibition of PTEN nuclear localization exacerbates Shp2 E76K-induced hyperproliferation; and (B) co-transduce conditional PTEN knockout bone marrow cells with WT Shp2 or Shp2 E76K and PTEN-NLSSV-40, which forces nuclear localization of PTEN, to investigate whether gain-of-function mutant Shp2 E76K causes decreased nuclear localization of PTEN by promoting its egress from the nucleus. We expect that the results of these studies will enhance our understanding of the role of PI3K signaling in the pathophysiology of activating PTPN11-induced JMML, potentially providing novel molecular targets for this disease.

Public health relevance
PROJECT NARRATIVE Juvenile Myelomonocytic Leukemia is a deadly blood cancer in children. Our laboratory has developed a series of experiments to help us understand how changes in a protein called Shp2 along with another protein called PI3K can cause normal blood cells to become cancerous in the hope of developing a treatment, which currently does not exist. __SpecificAimsTextDelimiter__ STATEMENT OF HYPOTHESIS AND SPECIFIC AIMS Juvenile myelomonocytic leukemia (JMML) is an untreatable myeloproliferative disorder (MPD) of children < 5 years of age characterized clinically by overproduction of myelomonocytic cells and by the in vitro phenotype of hematopoietic progenitor hypersensitivity to granulocyte-macrophage colony-stimulating factor (GM-CSF). Activating mutations of the NRAS and KRAS genes and loss-of-heterozygosity of the tumor suppressor gene NF1 have long been recognized as pathogenic in this disease1-5. More recently, somatic mutations in PTPN11, which encodes the protein tyrosine phosphatase, Shp2, have been found in 35% of JMML cases. Standard cytotoxic chemotherapy in JMML is ineffective, producing few durable remissions6. Even following the rigorous therapy of allogeneic stem cell transplantation, the probability of event-free survival at five years is only 50%(7,8). Thus, novel improved therapeutic approaches are urgently needed for this disease. We have found previously that hematopoietic progenitors expressing the activating PTPN11 mutants Shp2 D61Y or Shp2 E76K demonstrate GM-CSF-stimulated hyperproliferation (9,10), elevated phospho-Erk and phospho-Akt(9,10), enhanced survival (10), and dysregulated expression of cell cycle regulatory proteins (10). Based on these findings, we are pursuing studies addressing the over-riding hypothesis that hyperactivation of class IA phosphoinositol-3-kinase (PI3K) induced by activating PTPN11 mutants contributes to the etiology of JMML. We have been examining the contribution of the PI3K regulatory subunit, p85alpha, to activating PTPN11-induced transformation using a murine model bearing genetic disruption of Pik3r1 (encoding subunits p85alpha, p55alpha, and p50alpha,Figure 1). We have found that disrupted expression of p85alpha as well as the two regulatory subunit splice variants, p55alpha and p50alpha, yields a significant, but incomplete, correction of hematopoietic progenitor hypersensitivity to GM-CSF induced by activating PTPN11 mutations. These findings indicate that the regulatory subunits p85alpha, p55alpha, and p50alpha participate in hyperactivation of PI3K, but that additional signaling elements contribute to activating PTPN11-induced PI3K hyperactivation and hypersensitivity to GM-CSF. Two potential factors contributing to the residual activating Shp2-induced hypersensitivity to GM-CSF in the absence of PI3K regulatory subunits p85alpha p55alpha, and p50alpha are 1) compensatory function of p85Beta an alternative PI3K regulatory subunit; or 2) reduced function or expression of the lipid kinase tumor suppressor, phosphatase and tension homolog (PTEN) (Figure 1). The objectives of the current application are to utilize a genetic murine model bearing genetic disruption of Pik3r2 (encoding p85Beta) in addition to Pik3r1 (encoding p85alpha, p55alpha, and p50alpha) to examine the role of p85Beta in activating PTPN11-induced leukemogenesis and to utilize a genetic murine model bearing a conditional knockout of PTEN to examine the functional role, expression, and subcellular localization of PTEN in activating PTPN11-induced leukemogenesis. Aim 1. We hypothesize that the PI3K regulatory subunit p85Beta works with p85alpha p55alpha, and p50alpha to induce GM-CSF hypersensitivity of myeloid progenitors bearing activating PTPN11 mutations. We will use murine hematopoietic cells lacking expression of the regulatory subunits of PI3K including p85alpha, p55alpha, and p50alpha (encoded by Pik3r1) and p85Beta (encoded by Pik3r2) with activating PTPN11 mutants to conduct in vitro hematopoietic progenitor biochemical analysis as well as examine the development of MPD in vivo. Aim 2. We hypothesize that reduced PTEN function exacerbates activating PTPN11-induced PI3K hyperactivation and hematopoietic progenitor sensitivity to GM-CSF. We will (A) cross conditional Shp2 D61Y gain-of-function knockin mice with conditional PTEN knockout mice to assess if PTEN haploin sufficiency contributes to activating Shp2-induced MPD in vivo; and (B) investigate primary hematopoietic progenitor cells obtained from these mice to determine whether PTEN deficiency contributes to increased Shp2 D61Y-induced hyperproliferation and Akt phosphorylation in vitro. Aim 3. We hypothesize that reduced nuclear PTEN localization in hematopoietic progenitors expressing activating PTPN11 mutants contributes to hyperactive PI3K-induced transformation. We will (A) co-transduce conditional PTEN knockout bone marrow cells with Shp2 E76K and WT PTEN or mutant PTEN K289E, which abrogates monoubiquitination-mediated nuclear translocation, in order to investigate if inhibition of PTEN nuclear localization exacerbates Shp2 E76K-induced hyperproliferation; and (B) co-transduce conditional PTEN knockout bone marrow cells with WT Shp2 or Shp2 E76K and PTEN-NLSSV-40, which forces nuclear localization of PTEN, to investigate whether gain-of-function mutant Shp2 E76K causes decreased nuclear localization of PTEN by promoting its egress from the nucleus. This work is innovative, because it capitalizes on the use of genetically altered hematopoietic progenitor cells that lack the expression of one or more critical signaling components that contribute to MPD via activating mutations of PTPN11. It is our expectation that the resultant approach will identify the full range of functions that contribute to MPD in vivo and abnormal phenotypes in vitro via the PI3K pathway due to the presence of activating PTPN11. These results will be significant, because they are expected to provide new targets for molecular therapies for the treatment of JMML.